Food Defense and Surveillance in Support of the FDA by the State Hygienic Laboratory at the University of Iowa

RFA-FD-25-007 Application | Overall Project Summary/Abstact
The assurance of food safety that has been developed and sustained within the State Hygienic Laboratory
(SHL) at the University of Iowa is a high-quality, performance-based effort that enhances public health,
protects consumers and promotes preparedness. The SHL, in conjunction with its partner Manufactured Food
Regulatory Program Standards (MFRPS) agency, the Iowa Department of Inspections, Appeals, and Licensing
(DIAL), comprise a proactive regulatory, response and surveillance team. This team effort minimizes risks in
food consumption for the public through efficient and effective sample collection, analysis and results reporting
to support the U.S. Food and Drug Administration goal of an integrated food safety system. The culture of food
safety at SHL is multidisciplinary, fully engaged at all levels and well-staffed with subject matter experts.
The State Hygienic Laboratory has been engaged in maintaining quality systems in the laboratory in
compliance with ISO/IEC 17025 since September 2013. SHL has maintained AIHA Laboratory Accreditation in
both the Coralville and Ankeny lab locations, specifically for the food scope by providing the resources -
including systems, equipment, and personnel - to ensure adherence to rigorous QA/QC protocols and
appropriate accrediting authority/agency standards. Over the past nearly five years DIAL has been an active
partner, collecting 75 samples per year in support of FDA LFFM Microbiological Human Food Testing, meeting
the goal set each year of the previous award.
The SHL is, and has been, an active and experienced participant in the FDA LFFM and the USDA FSIS FERN
Cooperative Agreement Programs, providing laboratory testing for chemical, microbiological, and radiological
contaminants in various food matrices for routine contaminants and threat agents.
The State Hygienic laboratory has develop a series of projects within this proposal to meet the following aims:
1) Ensure laboratory capacity for the analysis of foods and food products related to chemical, microbiological,
and radiological contamination that occurs as intentional, accidental or unknowing; 2) Strengthen and enhance
preparedness of the state public health laboratory to provide organized, timely and efficient response in urgent
and emergency situations/outbreaks; and 3)enhance currently validated analytical methods and strive to
validate/verify additional methods to accomplish program growth. SHL has the expertise, facilities, and
resources to execute the projects fully and hopes to continue as a valuable member of the FDA LFFM
Cooperative Agreement Program for many years to come.

Public health relevance
RFA-FD-25-007 Application | Overall Project Narrative This cooperative agreement is intended to enhance the capacity and capability to test human food for typical contaminants and threat agents in the state of Iowa in order to support of an integrated food safety system. Sample testing in the areas of microbiology, chemistry, and radiochemistry, as well as participation in future special projects will support and expand capacity and capability. Successful completion of this multi- disciplinary project will strengthen and improve the collaboration on surveillance testing between the FDA and the State Hygienic Laboratory and will help the FDA enhance its nationally integrated food safety system and reinforce the mission to detect, prevent, and minimize the effects of foodborne exposures.